University of Michigan Kidney, Urology and Hematology Research Training Network

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Abstract/Project Summary
The University of Michigan (UM) Kidney, Urology and Hematology Research Training Network (KUHR) was developed with the primary goal of creating an institutional infrastructure with resources to aid recruiting and preparing trainees (predoctoral to physician scientists and PhD postdoctoral fellows) for academic careers. The Program faculty mentors and trainees will pursue a broad translational science spectrum from the biological basis of disease to interventions that improve the health of individuals and the public in the KUH domain. The U2C component will coordinate and provide administrative support through its Administrative Core to achieve the goals of the Program, structured around the following Specific Aims. Aim 1: To train the next generation of scientists in KUH relevant areas. The TL1 supports a rigorous training program emphasizing research training themes based both on the critical need to develop well-trained investigators in all areas along the translational and cross-disciplinary spectrum of KUH disease research and on the investigative interest and expertise of program faculty members. Aim 2: To assist trainees with developing the skills broadly necessary for a successful career in research. Offerings from the Professional Development Core will support activities and curricula designed to enhance trainee research competitiveness in research, including building skills in leadership and communication, grant writing and professional networking. Aim 3: To ensure the provision of robust and skillful research mentoring. The Professional Development Core will also include specific curricula directed at preceptors to develop their mentoring skills. The Networking Core will develop systems and processes that support direct peer communication and near-peer mentoring amongst all trainees. Aim 4: To establish a pipeline for future trainees. Community outreach to attract early-career students (high school and undergraduate) into KUH research areas to provide networking opportunities, engage and prepare trainees for academic KUH disease research careers in the United States.

Public health relevance
PUBLIC HEALTH RELEVANCE The goal of the University of Michigan Kidney, Urology and Hematology Research Training Network is to establish an infrastructure to enable the recruitment and training of predoctoral and postdoctoral trainees. The Program will provide trainees with the skills necessary to pursue careers in research so that they can contribute to the development of advances in the prevention, diagnosis, and treatment of KUH diseases. This training program fills a critical need to increase the number of future leaders in KUH research.